ORAL SODIUM PHENYLBUTYRATE THERAPY FOR CHILDREN WITH SICKLE CELL ANEMIA

This research proposal is designed to test whether sodium phenylbutyrate (SPB) will increase fetal hemoglobin (HbF) in children with sickle cell anemia & thereby ameliorate complications from their disease. Red blood cell sickling occurs in patients with sickle cell anmia because deoxygenated hemoglobin S(HbS) aggregates into rigid, rod-like polymers. The normal bi-concave red blood cell disc assumes a sickle shape, which is much less deformable & tends to fragment in the circulation. Moreover, abnormal membraane properties cause adherence to the vascular endothelium. The combination of these physical abnormalities give rise to the anemia & vaso-occlusive phenomenon associated with the disease.